GENETIC THERAPY OF FABRY DISEASE

We have performed a series of preclinical investigations concerning gene therapy for Fabry disease. A recombinant retroviral gene transfer vector was designed that engineers efficient transduction of cells and expression of human alpha-Gal A activity. Enzymatic correction was observed in cultured skin fibroblasts and B cell lines derived from patients with Fabry disease. Corrected cells secreted significant quantities of alpha- Gal A into the culture medium. The secreted enzyme is taken up by uncorrected bystander cells. We have also achieved enzymatic correction in CD34+ and progenitor colony cells obtained from bone-marrow aspirates from patients with Fabry disease. A recombinant fusion protein has been engineered that combines the alpha-Gal A enzyme in frame with a carboxy- terminal eight amino acid addition called the FLAG peptide. This sequence is specific and antigenic when it is expressed. It can be detected with an antibody. This fusion protein will permit purification of extra- and intracellular forms of alpha-Gal A and provide direct evidence of uptake into bystander cells and lysosomal location. We are also producing retroviral vectors with selectable markers to increase expression by altering the viral or alpha-Gal A constructs or by sorting the transduced cells prior to implantation. We are also conducting experiments to optimize the transduction of CD34+ cells mobilized in peripheral blood. We are currently producing a high-titer clinical-grade vector under GMP conditions for gene therapy trials in Fabry disease.